Core--Clinical Facility

The Administrative and Clinical Core (Core A) will provide Project Investigators with the following: Monthly meetings to facilitate and initiate collaboration, review of Core performance, and peer review of research activities carried out in each of the Program Projects. A scientific Advisory Committee for oversight of scientific Core performance. Administration of the daily business operations of the Program including budgets, chargeback procedures and service contracts. Access to clinical samples from volunteer research experiencing acute and convalescent Epstein-Barr Virus infections. These samples will be obtained from the Core Mono Clinic at the Umass Student Health Service, Coordinated by a nurse practitioner. Viral serology and molecular HYLA Class I and II typing of clinical samples. The Administrative and Clinical Core will be utilized by investigators from Projects #1, #2, #3.